Glyco-MAP: a high-throughput multiplexed platform for Glycosylated Mucin Antibody Profiling with glycoengineered cell lines expressing well-defined homogeneous glycostructures

Glyco-MAP: a high-throughput multiplexed platform for Glycosylated Mucin Antibody Profiling with
glycoengineered cell lines expressing well-defined homogeneous glycostructures
Abstract
Early detection is critical to making inroads in the fight against cancer. Tumor antigens elicit tumor associated
autoantibodies (TAAb) during early cancer development that can serve as markers for cancer early detection.
However, the potential of TAAbs has not been fully realized because previous TAAb studies rely almost
exclusively on proteins that lack post-translational modifications, partly due to the lack of appropriate
technologies. Mucins are a class of heavily O-glycosylated proteins, whose expression and glycosylation are
dysregulated in cancer, making them an excellent target for cancer biomarkers. We propose using mucins as
model tumor antigens for the development of a high-through platform assaying TAAbs against glycosylated
proteins, namely Glycosylated Mucin Antibody Profiling (Glyco-MAP). The complexity of mucin type O-
glycosylation has historically posed challenges in dissecting different forms of endogenous glycosylated mucins.
To this end, we will rely on a set of O-glycoengineered cell lines with homogeneous O-glycosylation capacities
to express glycoproteins with defined O-glycan structures relevant to cancer. To screen many different
glycoproteins in many samples we will use a new method, called Multiplexed In Solution Protein Arrays (MISPA),
which combines immunoassays with next-generation sequencing (NGS) to simultaneously quantify hundreds of
antibody-antigen interactions. MISPA can work with antigens from any protein expression system if they possess
a HaloTag; however, so far it has been used predominately with in vitro expressed unmodified proteins. Glyco-
MAP will combine glycoengineered cell lines and MISPA for systematic glycosylated mucin antibody profiling.
HaloTagged human mucins will be expressed in O-glycoengineered HEK293 cell lines and covalently “barcoded”
with unique DNA sequences. Barcoded mucins and TAAb from patients' sera will be subsequently
immunoprecipitated. Individual sample indexing with unique DNA sequences added to protein barcodes, allows
for the processing of many samples in parallel. Quantification of DNA barcodes on precipitated antigens and
sample indexes using NGS provides a quantitative metric proportional to TAAb concentrations in each sample.
Glyco-MAP enables the testing of TAAb abundance against many glycosylated mucins in thousands of patient
samples with a single NGS run. We will analyze almost 1 million IgG and IgM antibodies in 400 patients with 2
major epithelial cancers and 400 cancer-free healthy controls against 40 mucins or glycoproteins with a mucin-
like domain with 14 distinct glycoforms with cancer relevance. Our proposed study is a close collaboration
between experts on proteomics technologies (Dr. Qiu) and glycobiology (Dr. Clausen). This profiling may find
new early cancer biomarkers. Understanding the interaction dynamics of glycosylated proteins and how they
change in disease is essential for elucidating cellular biology and disease mechanisms. Our study on TAAbs
against glycosylated mucins serves as an exemplary application for studying general biological interactions
dependent on glycans and unraveling the intricate interactions between the host and microorganisms.

Public health relevance
Project narrative Mucins, a diverse group of extensively O-glycosylated proteins, play crucial roles in various biological processes, including cell adhesion, recognition, and signaling. The dysregulation of mucin expression and glycosylation in cancer gives rise to tumor-associated antibodies, offering a promising avenue for early cancer detection. Our study aims to systematically profile antibodies targeting glycosylated mucins in four major epithelial cancers and healthy controls, presenting an opportunity to identify potential cancer biomarkers and enhance our understanding of the biological intricacies of glycosylated mucins.